Emergency Department-Initiated Medications for Alcohol Use Disorder

The objective of our study, Emergency Department-Initiated Medications for Alcohol Use Disorder
(1R01AA030568-01), is to compare outcomes among emergency department patients with alcohol use
disorder who are randomized to initiate treatment with naltrexone and gabapentin in the emergency
department with compared with those randomized to usual care. The purpose of this supplement is to support
the costs of conducting the study under IND status, including developing a 21 CFR compliant database,
external study monitoring, participant telephones and other associated costs.

Public health relevance
The objective of our study, Emergency Department-Initiated Medications for Alcohol Use Disorder (1R01AA030568-01), is to compare outcomes among emergency department patients with alcohol use disorder who are randomized to initiate treatment with naltrexone and gabapentin in the emergency department with compared with those randomized to usual care. The purpose of this supplement is to support the costs of conducting the study under IND status, as deemed necessary by the FDA.